Project-006

The main functions of the Network Capacity component of the UTMB CTSA Hub are to support networkwide
studies through our Trial Innovation Network (TIN) Hub Liaison Team and to link our hub with the CTSA
Program Central Resources, including the Center for Leading Innovation and Collaboration (CLIC) and the
Clinical Data to Health Coordinating Center (CD2H-CC). We will provide a nurturing environment to conduct
high-quality, efficient, and regulation-compliant multi-site clinical trials in our areas of unique strength. We
will continue to expand and enhance the clinical research and informatics infrastructure to provide more
opportunities for our investigators to participate in TIN multi-site clinical trials and CLIC and CD2H-CC
initiatives. We will also support the local development of multi-site studies to propose for dissemination by
the TIN and will disseminate our Informatics discoveries and our innovative Team Science training programs
nation-wide. We have strengthened and streamlined our clinical research infrastructure. We have integrated
the Hub Liaison Team with the Office of Clinical Research, the single point of contact for all clinical studies.
We have been working with our Informatics core to develop novel tools for clinical trial feasibility, patient
recruitment, clinical data extraction and reporting, and multi-hub software interoperability. We have worked
with Trials Today to establish a searchable customized UTMB trials website. The Hub Liaison Team will
leverage the OCR and the informatics advancements to develop high-quality multi-site clinical trials with high
recruitment yields at UTMB through its interactions with the TIN. The Network Capacity Specific Aims are: Aim
1. Optimize the UTMB Hub Liaison Team to improve access, rapidly respond to, and support CTSA
Network TIN studies. Aim 2. Support and link the CTSA Program Central Resources with the UTMB
Hub. Aim 3. Disseminate Team Science training to the CTSA Network. Effectiveness of the Network
Capacity activities will be measured using common metrics as well as metrics locally developed using our
continuous improvement methodology